NUTROPIN RECOMBINANT HUMAN GROWTH HORMONE IN POST RENAL TRANSPLANTATION

Poor growth in children with renal failure (CRF) may not be corrected with renal transplantation. Recombinant human growth hormone (rhGH), now in use to treat children with CRF pre-transplantation, may be effective post-transplantation as well, but may cause unique problems such as chronic rejection. This study is intended to study the efficacy and safety of rhGH treatment in this population.